CTSA Postdoctoral T32 at Wake Forest

PROJECT SUMMARY/ABSTRACT
A critical barrier to realizing the promise of the Academic Learning Health System (aLHS) is the insufficient
number of investigators with the skills to cross the research-practice chasm and create health systems in which
new knowledge is integrated into clinical practice. The realization of the aLHS requires a new translational
workforce phenotype – the aLHS Translational Scientist – who is grounded in several rapidly evolving, but
infrequently integrated knowledge domains, including: 1) system science and organizational change
management; 2) research questions and standards of scientific evidence; 3) health systems research methods;
4) biomedical informatics; 5) ethics of research and implementation in health systems; 6) improvement and
implementation science; 7) stakeholder engagement, leadership, and research management; and 8) health
equity and health disparities. This T32 application proposes an innovative two-year Academic Learning Health
System Scholars Program (aLHSSP) to provide the next generation of translational scientists with the
methodologic and professional skills to conduct rigorous research in the complex environments of health systems
and to disseminate and implement findings from such research into practice through: (1) building competency in
the above domains, (2) building skills in team science and leading effective interdisciplinary, diverse research
teams of engaged stakeholders; (3) preparing scholars for productive research careers in LHS science; and (4)
further developing scientific communication skills. The aLHSSP will target outstanding candidates with doctoral-
level clinical training in medicine and other health professions, or PhD-prepared scientists who wish to conduct
aLHS research. We will have a cohort of four trainees, two of which will be NCATS-supported. All trainees will
participate in a two-year program, pursuing an established Master of Science degree in LHS Science with a
curriculum designed around the knowledge domains listed above to prepare them to conduct research in an
aLHS and to lead teams. Scholars will conduct a mentored research project that addresses a pressing health
system issue guided by diverse mentoring teams consisting of experienced and committed subject-matter
experts, health system leaders, and near peer faculty, all of whom are well-grounded in the principles of effective
mentoring. Mentors will complete a 20-hr training via the Clinical and Translational Science Institute (CTSI)
Mentor Academy that addresses core mentoring competencies, and participate in multi-CTSA hub Mentorship
Symposia. The aLHSSP will be part of an integrated educational infrastructure at Wake Forest (WF) that includes
the Workforce Development Program; trainees will utilize CTSI resources, attend professional development
seminars, build networks with other WF T32 trainees and nationally with other CTSA hubs; they will have access
to extensive support services. This unique training experience will prepare scholars for future careers as learning
health system scientists who lead evidence-based integration of knowledge into clinical practice.

Public health relevance
PROJECT NARRATVE This Academic Learning Health System Scholars Program (aLHSSP) will provide the next generation of translational scientists with the methodologic and professional skills to a) conduct rigorous research in the complex environments of health systems, and b) disseminate and implement findings from such research into practice. The aLHSSP will offer a postdoctoral training experience that will lead to a Master of Science in Learning Health System Science; Scholars will also conduct a mentored research project that addresses a pressing health system issue. They will be guided by teams of experienced and committed faculty who are subject-matter experts and well-grounded in the principles of effective mentoring.